A Cognitive Behavioral Sleep Self-Management Intervention for Young Adults with Type 1 Diabetes

PROJECT SUMMARY/ABSTRACT
Only 2 in 8 young adults (age 18-30 years) with type 1 diabetes (T1D) achieve glycemic targets (A1C < 7.0%).
In well-controlled lab studies sleep deprivation impairs glucose tolerance and insulin sensitivity, a reduces acute
insulin response to glucose, impairs body weight regulation (lower leptin, higher ghrelin), and impairs alertness
in young adults without chronic conditions and decreases insulin sensitivity in middle-aged adults with T1D.
Using cognitive-behavioral approaches to sleep by 1 hour over 6 weeks to 12 months in natural environments is
feasible and contributes to improvements in insulin sensitivity, glucose tolerance, and general distress symptoms
in young adults without chronic conditions and improved time in glucose range in adolescents with T1D. Sleep
duration, regularity, and timing are modifiable targets that may improve glycemia and other important diabetes
self-management outcomes in young adults with T1D. Here we leverage our preliminary findings in the proposed
study to advance cognitive-behavioral sleep self-management for T1D (K99/R00NR018886). We propose to
enroll 248 young adults ages 18-30 years with T1D (50% female, 40% underrepresented) who are not achieving
glycemic targets (A1C ≥ 7%). The goals of this study are two-fold: (1) to compare the immediate and short-term
effects of a 3-month cognitive-behavioral sleep self-management intervention (CB-sleep) versus enhanced usual
care (time-balanced attention control) on sleep health dimensions and glycemia and (2) to determine whether
sleep health mediates the associations between the intervention and control condition over 9 months (baseline
to 3 months and 6 and 9 months post baseline). We will randomize 1:1 to the CB-sleep or enhanced usual care
condition (time balanced attention control). Sleep health dimensions will be rigorously measured using validated
tools: regularity (actigraphy and self-report), satisfaction (Patient-Reported Outcomes Measurement Information
System Sleep Disturbance), alertness (Epworth Sleepiness), timing, efficiency, and duration (actigraphy and
self-report). Glycemia will be determined by A1C (primary outcome) with subgroup analyses of glucose
variability/glucose percentage time in range 70-180 mg/dL (via continuous glucose monitors or self-monitored
blood glucose six times daily). Data will be analyzed using multivariate techniques, and efficacy will be
determined.

Public health relevance
PROJECT NARRATIVE Only two in eight young adults (18-30 years old) with type 1 diabetes achieve glucose targets and a majority are at an increased risk for complications such as premature coronary artery disease, stroke, vision loss, kidney disease and nerve damage compared to the general population. The primary goal of this study is to determine whether a cognitive-behavioral sleep self-management intervention can improve sleep health and glucose targets in young adults with type 1 diabetes. The key findings generated from this study including wearable technologies (e.g., actigraphy and continuous glucose monitors) may help support provider clinical decision making and self-management for young adult with type 1 diabetes to help them achieve glucose targets.